Visual pattern representation in the extrastriate cortex

Project Summary / Abstract
The goal of this research is to discover the cortical computations that determine the response properties of
neurons in visual cortical areas V2 and V4, two of the largest visual areas outside the primary visual cortex
(V1) in primates. These areas are critical conduits from the primary visual cortex to temporal lobe areas
responsible for the recognition and recollection of visually presented objects and scenes.
V2 receives a strong direct input from V1, and depends on V1 for its visual responsiveness. We have
developed a two-stage model, in which responses are constructed from a suitable combination of V1 afferents,
with the design of each stage following a common canonical form. We have characterized the strengths and
limitations of this model, and compared it in detail with a related neural net model trained on natural image
data. We will now extend and refine our model by giving it additional capabilities, and we will improve the
power of our fitting procedures by using data recorded simultaneously from populations of neurons.
The next step is to extend understanding to V4, which receives the bulk of its direct input from V2. We are not
yet ready to build a principled model of how V4 combines inputs from V2. We believe that V4’s functional
circuitry will be similar to that of V2, but in advance of the complete model for V2 we lack a precise account of
V4’s inputs. Measurements of V4 responses demonstrate enhanced representation of complex image features,
which encourages us to build a model based on both single-neuron and population responses to account for
the way it transforms input from V2. To complement the development of the neural model, we will also develop
and extend our neural network model that is trained on natural images.
A key component of V4’s response is its selectivity for complex forms. Our measurements of selectivity along
the image continuum between natural forms and statistically matched textures demonstrated that information
about this continuum is captured by relatively late components of the visual response. We will therefore use
reverse correlation methods to explore the nature and dynamics of V4 responses to textures, natural images,
and suitable image elements. We will also study responses to distorted natural images generated by a diffusion
model trained on natural images, which embody an implicit representation of the high dimensional space that
those images occupy. This will allow us to explore whether and how neurons in V4 and related areas have a
similar implicit representation of the universe of natural images.
The outcome of this work will be a new understanding of the functions of V2 and V4. These areas are of
interest both because of their potential as a substrate for visual loss and recovery after brain damage, and
because they are key parts of the processing chain by which visual signals are transformed to form decisions,
guide actions, and create enduring memories of evanescent events.

Public health relevance
Project Narrative Disorders of the visual nervous system are a major cause of visual disability: damage to the primary visual cortex (area V1) causes a loss of vision over part or all of the visual field, although parts of the visual cortex outside V1 may, in some cases, be able to substitute for some lost functions after V1 damage. Other disorders affecting these same areas outside V1 are associated with specific forms of visual loss such as akinetopsia (motion blindness) and agnosia (form blindness). Our research seeks to understand the organization and function of V2 and V4, the largest and most important cortical visual areas beyond area V1; these areas are of interest both because of their potential as a substrate for visual loss and recovery after brain damage, and because they are key parts of the processing chain by which sensory signals are transformed to form decisions, guide actions, and create enduring memories of evanescent events.